National Neuropsychological Network (NNN)

Project Summary
This proposal aims to develop a National Neuropsychology Network (NNN), starting with four clinical research
sites in California, Florida, Georgia, and Wisconsin. The NNN aims to gather clinical diagnostic information
following a shared protocol, collect item-level data on representative neuropsychological (NP) instruments, and
deposit these data in the NIMH Data Archive (NDA; https://data-archive.nimh.nih.gov/), more specifically in the
Research Domains Criteria database (RDoCdb). The infrastructure established in the network focuses on point-
of-testing data acquisition, using iPads, leveraging existing technology developed by a leading test vendor (Q-
interactive, from Pearson), and developing additional software to collect specific additional measures that are
widely used in clinical neuropsychology laboratories and clinics but which are not available elsewhere. The NNN
will collect data on more than 10,000 cases over 4 years, representing a broad range of neuropsychiatric
disorders, reflecting populations seen nationwide, and then deposit all data in RDoCdb. Data analyses will
specify the latent constructs underlying each test, the factors represented by larger batteries, and create
proposals for new individual tests and batteries. Novel tests (short forms and adaptive tests) will be suggested
based on item-response theory modeling of each test, with desired precision of measurement for evidence-
based clinical decision-making. Novel battery proposals will be informed by examining the positive and negative
predictive power of each test to contribute to key differential diagnostic questions that arise in NP assessment.
Both battery and individual test proposals will focus on efficiency, and are expected to yield at least a doubling
of efficiency. The NNN aims to serve as a nucleus and template for additional network nodes, that will in its next
generation offer a national platform for co-norming novel tests, expanding to other languages, and ultimately
designing new procedures that are validated with respect to both brain function and real world adaptive
capacities.

Public health relevance
Project Narrative Most neuropsychological methods used to measure brain function today in both clinical and research settings are more than 5 decades old and introduction of superior methods is limited by inertia in clinics nationwide, which rely on traditional validity standards. The proposed research establishes a network of research clinics capable of generating data that will inform the development of novel procedures that are evidence-based and markedly more efficient than current methods. These advances will improve the quality of neuropsychological methods for both research labs and clinics, and ultimately be central to enhancing access to neuropsychological services nationwide.